Sleep, circadian rhythms: associations with diabetes risk and mood

ABSTRACT
This diversity supplement application is to support the career development of Doreen Egan, MPH, a PhD
student in the University of Utah PhD program in Public Health. The parent grant (1R01HL141706-01A1)
entitled “Circadian and sleep pathways to cardiometabolic disease risk: role of neurobehavioral processes” is a
longitudinal, observational study examining the role of sleep and circadian rhythms in neurobehavioral
processes related to obesity (e.g., impulsivity). As described in the candidate plan, Ms. Egan is from an
underrepresented ethnic background (Pacific Islander/ Tongan), is a US citizen and is therefore eligible to
apply for diversity funds. In addition, Ms. Egan’s application is distinguished by her military service (Army). We
are requesting 3 semesters of funding for her career development to support achieving her goal completing her
PhD programs in Public Health and preparing for her next step postdoctoral position. Results of this project will
support the completion of her dissertation and enhance her skills needed to transition to a postdoctoral position
and beyond.
The goals of Ms. Egan’s project are to examine sleep and circadian rhythms with suicidal ideation, depression
and diabetes risk. The relationships between suicide and diabetes are novel and timely, and the role of sleep
and circadian rhythms have not been explored. Ms. Egan will contribute to achieving the aims of the parent
grant and complete analyses that will enhance both her training and the findings of the parent grant.
The mentoring and training plan will allow Ms. Egan to increase her knowledge of sleep and circadian rhythms,
increase skills in data analysis and gain experiences in writing and scientific presentations. Her mentors on the
team (Drs. Baron, Jing) are experienced mentors and well-suited to support her professional development in
this supplement.

Public health relevance
Project Narrative This diversity supplement will advance the understanding of the role of sleep and circadian rhythm disruption in mood disorders/suicidal ideation and glucose. Results may inform novel targets to improve mental health and reduce suicide risk.